Personalized Seizure Forecasting: A Precision Medicine Approach

PROJECT SUMMARY
The hallmark of epilepsy is recurrent seizures, i.e., paroxysmal attacks of abnormal brain electrical activity that
are associated with high morbidity and premature mortality. In addition to the direct morbidity of seizures,
people with epilepsy must also contend with the ever-present uncertainty about when the next seizure will
occur. The unpredictability of seizures represents a significant and disabling feature of epilepsy. Despite
decades of research, there is no established method for determining when a seizure could occur. Akin to
weather forecasts that estimate the probability of rain, seizure forecasts that quantify the likelihood of seizures
over a future temporal window could increase the quality of life for patients and families living with epilepsy, so
they could plan around a seizure event. A forecast could help patients and families prepare for, or even
mitigate upcoming seizures. The overarching goals of the present proposal are (1) to elucidate the relationship
between biochemical changes in saliva (a readily available biofluid that reflects systemic chemistry) and
electrophysiological features that determine seizure likelihood (recorded from a Responsive Neurostimulation
(RNS®) System) and (2) to leverage these relationships to develop effective seizure forecasting methods that
will empower people with epilepsy with the unprecedented ability to anticipate and prevent seizures. We have
strong preliminary data from people with epilepsy that several saliva chemicals exhibit novel multidien (multi-
day) and circadian (~24-hour) concentration changes that correlate with periods of increased seizure
likelihood. Our central hypothesis states that a latent biochemical variable for seizure likelihood can be
detected in people with epilepsy using serial salivary sampling. We will pursue the following specific aims: (1)
establish biochemical signatures of multidien seizure likelihood and develop effective seizure forecasting
approaches; and (2) establish biochemical signatures of increased seizure likelihood over the circadian cycle.
Successful completion of this project will significantly advance the fields of chronobiology, metabolism, and
epilepsy by: (a) identifying novel multidien and circadian rhythms in biochemical and metabolic pathways in
people with epilepsy and healthy controls, (b) linking these changes to possible causes of seizures, and (c)
using these changes to forecast seizures and define a more effective standard of care. The expected positive
impacts on public health will be to (a) empower people with epilepsy with the ability to anticipate and prevent
seizures, (b) provide researchers with validated saliva sample collection and analysis approaches, and (c)
discover ground-breaking biochemical insight into the human chrono-metabolome. Detailed knowledge about
the chrono-metabolome is expected to fuel innovative studies on various episodic brain disorders that place a
large burden on society, like migraine, cluster headaches, affective disorders, and substance use disorders.

Public health relevance
NARRATIVE The proposed research will advance public health by discovering factors, such as biochemical and metabolic changes, underlying seizure initiation in people with drug-resistant epilepsy. This essential knowledge will revolutionize a new standard of care by forecasting and treating epileptic seizures in a population with few treatment options. The research is in line with the NIH / NINDS’ mission of seeking fundamental knowledge about the brain and nervous system and to use that knowledge to reduce the burden of neurological disease.